Time-restricted feeding (TRF) for prevention of age-related vascular cognitive impairment and dementia

PROJECT SUMMARY/ABSTRACT
Candidate: Stefano Tarantini, PhD is a young assistant professor in the Center for Geroscience at the University
of Oklahoma HSC. Dr. Tarantini’s research is focused on the role of age-related dysregulation of cerebral blood
flow in the pathogenesis of Vascular Cognitive Impairment and Dementia (VCID). Dr. Tarantini’s long-term goal is
to independently lead a federally funded laboratory with research focused on the underlying causes for the
pathogenesis of VCID, and development of novel interventions for prevention targeting basic mechanisms of aging.
Career Development: This R03 award will support Dr. Tarantini’s research efforts investigating a novel pilot study
building on his past experience in cerebrovascular pathophysiology, advanced two-photon imaging,
transcriptomics, bioinformatics, cognitive testing, redox biology and metabolic biology.
Rich research environment: The Center for Geroscience at University of Oklahoma HSC is a leading center in
VCID research and is an ideal environment for Dr. Tarantini’s career development, providing all the resources
required to successfully complete the proposed studies. This proposal builds on the existing significant strengths:
multidisciplinary expertise, cutting-edge core facility infrastructure, highly collaborative environment, and an
exceptionally successful model for junior faculty mentoring.
Research: The proposal aims to investigate the potential role of time-restricted feeding (TRF) against the
development of age-related vascular cognitive impairment. Nutritional interventions such as caloric restriction (CR)
have been shown to exert positive effects against endothelial dysfunction however poor adherence to CR and
some deleterious effects in older individuals generate the need to investigate alternative translatable strategies
against cognitive decline in the elderly. On the basis of extant preliminary data, the central hypothesis is proposed
that TRF reverses age-induced endothelial dysfunction and improves CBF and NVC responses. It is predicted that
the resulting neurovascular rejuvenation contributes to restoration of cognitive function. The following aims are
proposed: 1) Determine how TRF regimen affects endothelium-mediated neurovascular coupling responses in
aging; 2) Determine how TRF as a lifestyle intervention alters multiple cognitive domains in aging. The studies that
have been highlighted in this proposal will investigate pathways that lead to the pathogenesis of VCID and offer
potential therapeutic strategies to prevent the loss of cognitive function in the elderly.
Deliverables: The results from the proposed studies will provide mechanistic insight into the endothelial
contributions to age-related VCID and provide proof-of-concept for the development of nutritional lifestyle
intervention strategies for prevention.

Public health relevance
PROJECT NARRATIVE Age-related vascular cognitive impairment and dementia (VCID) is a leading public health concern in developed countries to which no treatment exists to this day. Impaired adjustment of cerebral blood flow to neuronal activity (through a mechanism termed neurovascular/gliovascular coupling) in aging contributes to the pathogenesis of VCID. The purpose of this proposal is to determine how a nutritional lifestyle intervention (time- restricted feeding) regimen can ameliorate endothelial dysfunction leading to cerebrovascular gain of function and prevention of age-related cognitive impairment.